RD, PC PROS TRIAL OF EFFICACY &SAFETY OF OXANDRIN IN TX OF DMD ANCI

This is an ancillary study being performed in conjunction with protocol 600. The purpose of this study is to document changes in muscle mass and protein breakdown in muscle over a six month period in patients enrolled in the Oxandrin protocol.